Hyperpolarized MRI Technology Resource Center

Training & Dissemination Summary/Abstract
The overall goal of this P41 center is to develop and disseminate novel hyperpolarized (HP) 13C MR technologies
with requisite training/documentation to advance significantly this emerging molecular imaging approach for both
preclinical scientific studies and clinical research. This has always been a critical aspect of the HMTRC and it
will continue to develop and grow in new ways within this proposed renewal application. As defined in our Specific
Aims, the HMTRC training and dissemination programs are designed to have a broad national impact for the
advancement of HP C-13 MRI technology development and research. As stated in the 2021 EAC report: “The
HMTRC has led the nation (and the world) in the development and translation of HP MRI through a unique
combination of skills, expertise, instrumentation, environment, clinical engagement, and industry engagement,
which simply does not exist elsewhere. The HMTRC will continue to serve as a critical national resource through
the next funding cycle as the field of HP MRI expands and matures, particularly with the clinical translation of
new HP agents, and more sites engaging in research involving human subjects. The restructured Center benefits
from clear and enhanced synergy between all TR&Ds and Collaborative Projects that are more broadly
geographically distributed. HMTRC programs for training and dissemination remain outstanding. Progress in the
engagement and stimulation of clinical interest is nothing short of remarkable, and crucial for the continuing
growth and development of this field.”
This NCBIB’s Training & Dissemination in HP C-13 MRI will focused on: 1) Hands-on and formal course training
of local MS/PhD students, post-docs, Radiology residents and fellows. 2) Collaborative Project (CP) investigators
will receive specialized training relevant to their particular needs. 3) Junior Faculty will receive support by the
department and HMTRC for specific training and mentoring to establish independent HP C-13 research
programs. 4) Extramural Visitors from over 55 different sites have come to the HMTRC through the workshops,
and longer individual visits to see the latest hardware & receive hands-on training and this would be expanded.
5) Hyperpolarized MRI Technology Workshops. These "hands-on" workshops provide unique information,
training, and interactions focused on the technical aspects of HP 13C MR preclinical and translational research
and analysis from all TRDs. 6) New Center Website will be a key component in the dissemination & training of
tools, resources and technologies developed by this NCBIB. In this renewal, we will expand virtual training by
providing new videos and documentation on HP 13C MR technology developments, “How-to” tutorials, training
modules and recorded workshop, course lectures, & HP 13C seminar presentations. Also direct technology
dissemination to CPs, SPs, & the wider HP 13C community will be supported.